Research Training for Physician-Scientists in Gastrointestinal Oncology

Summary
This is the first application for renewal of T32 CA193111 to continue funding the training of next generation of
physician-scientists in gastrointestinal oncology. We believe that physician-scientists armed with rigorous
research training are necessary to discover and translate new advances in GI oncology as well as to investigate
critical issues facing delivery of cancer care to patients. Our trainees are drawn from NYU’s renowned clinical
fellowship programs in Medical Oncology or Gastroenterology or top-notch residency programs in Radiation
Oncology or Surgery. Trainees take a 2-3 year hiatus from clinical activities to engage in intensive full-time
training in GI cancer research. Our program is composed of (i) a Basic/Translational Science track aimed at
individuals who wish to direct their own basic science laboratory in GI oncology or individuals who want to lead
translational research programs that comfortably interface between the pre-clinical laboratory and clinical
investigation and (ii) a Population Sciences tract for trainees who seek careers in the diverse fields of population
sciences including cancer epidemiology, comparative effectiveness, disparities, health services, or outcomes
research. The program for our Basic/Translational Science track consists of two years of individualized mentored
research in faculty laboratories, enhanced by a strong parallel didactic program in cancer biology. The Population
Sciences track is centered on a rigorous Masters-level curriculum that teaches clinical trial design, epidemiology,
comparative-effectiveness, and outcomes research methodologies along with a mentored research project
based in population sciences. The two tracks are united through a weekly 2-hour core curriculum covering
essential topics in GI cancer and critical lessons for cancer physicians embarking on independent investigative
careers. We plan to continue to have a steady-state of 4 trainees at any given time. Our first group of graduates
have been very successful in acquiring the research skills and credentials to eventually lead their own research
groups. We are proud that our first graduates have obtained academic positions in oncology and submitted highly
scored K grants. Our trainees are nurtured by a cadre of mentors with substantial accomplishments in cancer
research and stellar training records. The aim of our training program is to continue to graduate physician-
scientists armed with the intellectual capacity and tools to lead their own research programs and become leaders
and role models in investigative GI oncology.

Public health relevance
Narrative A renewal of this T32 program designed to continue training aspiring physician-scientists in GI cancer research. Trainees are drawn from Medical Oncology, Radiation Oncology, Surgery, and Gastroenterology and will enroll in either a Basic/Translational Science track or a Population Science track led by mentors accomplished in both scientific research and training. Our goal is to graduate physician-scientists armed with the capacity and credentials to lead their own innovative research programs and develop into leaders in investigative GI oncology.